CANCER CENTER SUPPORT GRANT

This Cancer Center Support (Core) Grant will be used to facilitate realization of the objectives of the Cancer Research Center within City of Hope, that is: 1) to create a climate for collaboration among basic scientists, clinical researchers and physicians for innovative laboratory and clinical research; 2) to provide personalized interdisciplinary care of the highest quality for every cancer patient at City of Hope; 3) to interact in cancer education and care with community physicians and other cancer centers.